Using Artificial Intelligence to Predict Cognitive Training Response in Amnestic Mild Cognitive Impairment

Project Summary/Abstract:
This K23 Clinical Trial project will provide Dr. Gullett, an Assistant Professor at the University of Florida, the direct
mentored-training needed to address important questions related to intervention response in an amnestic mild
cognitive impairment (aMCI) diagnosed population at risk for Alzheimer’s disease. As a neuropsychologist, Dr. Gullett
has gained clinical experience in the assessment of neurodegenerative diseases including Alzheimer’s disease and
its precursor, MCI, as well as research experience using structural neuroimaging to investigate various clinical
disorders. The support provided by the K23 mechanism through the NIA will provide Dr. Gullett with the protected
mentored-training needed to build on his current skills and become an expert in clinical neuroscience, machine
learning, and behavioral interventions for mild cognitive impairment and Alzheimer’s disease.
Career development and training plan: Dr. Gullett’s training plan consists of foundational formal coursework in 1)
clinical trials, 2) MCI and Alzheimer’s disease effects, and 3) biostatistics and machine learning investigative
techniques. These foundations will be directly applied through mentorship by experts in the fields of behavioral
cognitive interventions, neuroimaging, and machine learning, as well as a proposed in-person workshop in functional
neuroimaging analysis. This mentored-training plan will provide Dr. Gullett with the expertise to not only carry out the
proposed project, but to become a unique and invaluable resource for future collaborative efforts applying
neuroscience-based machine learning tools to investigate personalized interventions for Alzheimer’s disease.
Research plan: The proposed project will provide the clinical trials training needed for Dr. Gullett to establish the
effectiveness of a planned take-home, 12-week cognitive training program in patients with amnestic mild cognitive
impairment (N=75; Aim 1). The expert mentorship team proposed has decades of experience in behavioral clinical
trials interventions, which will provide the applicant with design and methodology guidance, as well as the recruitment
infrastructure and resources needed to successfully carry out the proposed project. Further, this project will provide
training in multi-modal neuroimaging-based machine learning to determine the baseline neural, cognitive, and
functional factors that distinguish aMCI patients who respond to treatment from those who do not (Aim 2). This
innovative approach will ultimately allow the applicant to investigate which of a myriad of features aMCI patients
possess at a baseline assessment are the most salient predictors of their ability to improve from a well-validated
cognitive training intervention. A project such as this will enable Dr. Gullett to develop a unique skillset to facilitate an
R01-level academic career tasked with providing individual aMCI patients personalized interventions based on their
own unique neurobiological and cognitive features.

Public health relevance
Project Narrative/Relevance to Public Health: Patients in the early stages of Alzheimer’s disease each display a unique pattern of altered brain structure, function, and thinking and memory skills. Knowing that their diagnosis of amnestic mild cognitive impairment (aMCI) places them at risk for developing Alzheimer’s disease, patients often seek out intervention to delay the progression of the disease without knowing whether it will truly provide benefit. This project will use advanced machine learning tools to provide detailed predictions of aMCI patients’ likelihood of improving from a widely supported cognitive training intervention, and clarify how an individual patient’s brain and cognitive features contribute to their response-to- intervention.